INDUCTION OF POLYOL PATHWAY ENZYMES IN DIABETES MELLITUS

The hypothesis is that patients with increased AR activity will generate increased polyol from glucose, and this increased influx alters cell and tissue function com[promising organ function. While we are targeting the peripheeral nerve, we also would apply the hypothesis to the kidney, the retina, and the heart, as well as connective tissue generally.